Serotonergic control of spine morphology

Project Summary
The spine provides support to the skeleton and muscles. Adolescent idiopathic scoliosis (AIS), a deformity in
which the spine curves during growth, impacts 3-4% of the population, most commonly girls. AIS causes
chronic pain and disfigurement. Scoliosis also associates with congenital vertebral malformations that can be
caused by defective patterning and formation of the notochord. Since we don't understand the basis of spine
deformity, surgery or bracing are often only corrective measures. But these are expensive, painful, and not
available to most. We aim to discover mechanisms of spine development, growth, and maintenance, including
how these go wrong when curves arise, to provide a framework for treating spinal deformity. The potential role
of the small molecule serotonin (5-HT) in spine morphology has been debated for many years. Removal of the
pineal gland, a major source of 5-HT, causes curves in some animals, while changes in 5-HT levels occur in
severe scoliosis patients. Using zebrafish, a tractable model of spinal deformity in which we have a great deal
of expertise, our proposal will functionally and mechanistically link 5-HT and spine morphology. We have
already discovered that loss of Tph2, a neuronal 5-HT-generating enzyme, causes significant spinal defects in
zebrafish, supplying a strong premise for our work. In aim 1, we will perform spatial- and temporal- genetic
perturbations to determine when and where 5-HT functions to control spine morphology. In aim 2, we will
determine the roles of 5-HT in controlling Reissner fiber formation, subcommissural organ gene expression
and notochord patterning, pathways known to control spine morphology. We have generated preliminary data
which link 5-HT to these pathways. Our work to discover mechanisms underlying 5-HT function in spine
morphology will be impactful because of the links between 5-HT and human scoliosis; thus, modulating 5-HT
and related pathways may be an important avenue for non-invasive treatments.

Public health relevance
Project Narrative Spinal dysmorphology like scoliosis represent common conditions that are painful and debilitating for patients, with the mechanisms underlying being little understood. We have discovered that serotonin is an essential signal that maintains the zebrafish spine. Since there are also intriguing links between serotonin levels and human scoliosis, our project to elucidate mechanisms through which serotonin controls spine morphology promises new opportunities for improving human health.